Targeting the PTH1R Signaling Pathway for Osteoarthritis Therapy by a Novel Disruptor Peptide

Project Summary/Abstract
The long-term goal of this project is to design cost-effective anabolic agents with less toxicity, and convenient
use for the treatment of osteoarthritis (OA). Current treatments of OA have limited effects on the prevention
and progression of cartilage degeneration. Complex signaling events in cartilage underlie OA pathogenesis
and these can be targeted. Parathyroid hormone (PTH) and parathyroid hormone-related protein (PTHrP) bind
to the type I PTH/PTHrP receptor (PTH1R) to elicit both Gs/cAMP and Gq/PLC signaling pathways. Published
as well as our preliminary data demonstrate a PTH1R Gs/cAMP signaling arm that is therapeutic and a
Gq/PLC signaling arm that is pathogenic. Beta-catenin mediates canonical Wnt signaling, facilitates
chondrocyte hypertrophic differentiation and plays an important role in OA development. However, the
interplay between PTH1R and beta-catenin that contributes to OA pathogenesis remains poorly understood.
Recent data from others and our group have demonstrated that beta-catenin interacts with the PTH1R and
switches PTH1R signaling from Gs/cAMP to Gq/PLC activation. Moreover, beta-catenin expression is
increased in human OA, the outcome of which promotes the PTH1R signaling switch and causes articular
cartilage loss and OA development. It has been established that systemic or intra-articular administration of
PTH or PTHrP is able to prevent cartilage degeneration and regenerate the damaged cartilage. However, daily
injection of PTH or PTHrP is inconvenient and reduces medication adherence. PTHrP is normally secreted by
chondrocytes in low levels and is increased in OA. The carboxyl-terminal region of six amino acids is the beta-
catenin binding site in PTH1R. Our preliminary studies have determined that this six-amino-acid peptide
(disruptor peptide) blocks beta-catenin binding to PTH1R. Based on these findings, we hypothesize that the
disruptor peptide biases endogenous PTHrP-induced PTH1R signaling to favor the therapeutic signaling arm
and improve the ability of PTHrP to inhibit cartilage degeneration and treat/prevent OA. Three specific aims are
proposed to test this hypothesis. Aim 1 will develop a superior disruptor peptide (SDP) to efficiently block the
interaction of beta-catenin with PTH1R and inhibit the beta-catenin-mediated PTH1R signaling switch. In Aim
2, we will establish whether the adeno-associated virus expressing SDP prevents cartilage lesions and
increase cartilage repair in a mouse OA model. Aim 3 will characterize mechanisms by which the SDP
regulates PTHrP effects on chondrocyte hypertrophic differentiation and chondrocyte catabolism. Successful
completion of these studies therefore constitutes important preclinical findings that would facilitate
advancement of this work toward clinical trials of OA, and ultimate application in humans.

Public health relevance
Project Narrative The goal of this proposal is to elucidate how manipulation of PTH receptor interaction with beta-catenin can prevent cartilage lesions and increase cartilage repair via shifting the PTH receptor signaling toward its therapeutic pathway. Thus, the therapeutic strategies in the present proposal help overcome the limitation of current usage of PTH or PTHrP for the prevention and treatment of osteoarthritis.